High-Resolution Pseudouridine and m6A Sequencing Through Advanced Nanopore Adduct Analysis

Project Summary
The landscape of transcriptomic and epitranscripotmic research is on the cusp of a revolution, with RNA
modifications playing pivotal roles in understanding gene expression, regulation, and the manifestation of
diseases. Among these modifications, pseudouridine (Ψ) and N6-methyladenosine (m6A) are of significant
interest due to their prevalence and impact on RNA stability, protein synthesis, and cellular stress responses.
However, current RNA sequencing technologies have low accuracy and precision in detecting RNA modifications
and are only able to inspect one modification at a time, thus limiting our understanding of their biological role,
and our ability to develop RNA-based diagnostics and therapeutics. RNA direct nanopore sequencing is an
attractive approach to sequencing many modifications at once. However, the current commercial nanopore
sequencer is limited by a high error rate in detecting Ψ and m6A because Ψ and m6A fail to yield quantitatively
unique sequencing signatures relative to their parent nucleotides and other RNA modifications; consequently,
the false discovery rate is too high for any clinical application and single molecule analysis is not possible. To
fully understand the roles of these crucial epitranscriptomic modifiers, it is essential to accurately and
concurrently sequence both modifications within a single experiment. This Phase I STTR project, a collaborative
effort between academia and industry, is set to develop the first technology capable of high-accuracy sequencing
of Ψ and m6A, by merging Distinguished Professor Cynthia J. Burrows' innovative bisulfite adduct methodology
with Electronic BioSciences’ (EBS) enzyme-free, multipass nanopore nucleic acid characterization technology.
This innovative approach aims to accurately identify Ψ and m6A modifications with unprecedented precision
(>99.9%), overcoming the limitations of current sequencing methods. The project is structured around two
primary aims: 1) The analytical validation of sequencing RNA with Ψ and m6A modifications using our novel
technology, and 2) The application of this technology to sequence mRNA from renal cell carcinoma cells,
providing insights into the epitranscriptomic landscape of this cancer. Expected outcomes include the
establishment of the first sequencing platform capable of high-precision and simultaneous mapping of Ψ and
m6A modifications, offering a significant advancement in the field of RNA research. This technology will not only
enhance our understanding of gene regulation and disease mechanisms but also pave the way for novel
diagnostics and personalized RNA-based therapies. Through its approach and potential applications, this project
represents a significant step forward in the quest to unravel the complexities of the RNA epitranscriptome, with
broad implications for medical science and therapeutics. Ultimately, this project embodies a strategic effort to
advance our capability to study RNA modifications through innovative technology that will be poised to deliver
solutions to sequence many other chemical changes to RNA as well.

Public health relevance
Project Narrative Developing a high-precision sequencing technology for pseudouridine (Ψ) and N6-methyladenosine (m6A) is set to transform disease diagnosis and treatment by facilitating precise detection and quantification of these essential RNA modifications. Bringing this advanced sequencing tool to market will be invaluable to epitranscriptomics researchers, leading to the creation of novel RNA-based diagnostic tests and targeted therapies, significantly enhancing patient outcomes and advancing personalized medicine.